An enzyme-based assay for the detection of acetaldehyde-protein adducts

ABSTRACT
Chronic alcohol consumption is a significant issue worldwide which can lead to addiction and damage
throughout the body. The first step in alcohol metabolism is its conversion into acetaldehyde, which is a highly
reactive and toxic molecule. The formation of acetaldehyde adducts with protein and DNA is a primary
mechanism of ethanol toxicity. Acetaldehyde adducts are a direct biomarker for alcohol abuse. We intend to
develop a facile and rapid enzyme-based assay for measuring acetaldehyde-protein adducts to assess alcohol
use and alcohol-related health consequences.

Public health relevance
NARRATIVE Acetaldehyde-protein adducts are a direct biomarker for chronic alcohol consumption. Developing technology to measure the levels of acetaldehyde-protein adducts is critical for diagnosing alcohol use disorder and assessing alcohol-related health consequences.